ONCOGENE ACTIVATION AND EXPRESSION IN RODENT TUMORS

Recent evidence from two independent lines of investigation has merged to suggest that neoplasia results from the abnormal activation of a relatively small number of cellular genes. Certain retroviruses contain transduced cellular genes which infer tranforming properties to the retrovirus. The retroviruses containing these cellular sequences in their genome can induce tumors in animals or transform cells in vitro. Subsequent studies have established that proto-oncogenes can also be activated as oncogenes in naturally occurring tumor cells by mechanisms completely independent of retroviral involvement. These genetic alterations range from point mutations to gross DNA rearrangements such as translocation and gene amplification. We have initiated studies to investigate oncogene activation and expression in spontaneous and chemical-induced tumors in rodents. Results to date have characterized the properties of activated oncogenes in spontaneous tumors as well as some chemically-induced tumors in rats and mice. These studies have provided data which show that oncogene activation in spontaneous tumors is different, in some cases, from that observed in chemically-induced tumors, thereby providing a possible approach to substantially increase sensitivity of rodent bioassays for detection and classification of carcinogens according to mechanism of action. This would enable us to more accurately estimate risk of cancer in humans exposed to specific classes of carcinogens by removing many of the uncertainties inherent in the process when more grosss biological endpoints are used.